Development of LPA5 Antagonists as Analgesics

Neuropathic pain is a debilitating and complex medical condition and afflicts millions of people in the US and
globally. Opioids are the most clinically used analgesics for pain management; however, their physical
dependence and abuse liability pose serious public health challenges and mounting economic burdens to the
society. There is clearly an urgent need for safer non-opioid analgesics. Lysophosphatidic acid receptor 5 (LPA5,
previously known as orphan receptor GPR92) is highly expressed in tissues related to pain processing such as
spinal cord and dorsal root ganglion (DRG). Activation or upregulation of the LPA5 receptor is observed in
response to nerve injury- and multiple sclerosis-induced neuropathic pains. Genetic KO or blockade of LPA5 by
antagonist AS2717638 displayed significant analgesia against cold or mechanical allodynia induced by nerve
injury as well as adjuvant induced inflammatory pain, while normal pain sensation in LPA5 KO mice is not altered.
These results strongly supporting LPA5 as a novel analgesic target and LPA5 antagonists as novel analgesics.
Existing evidence suggests medication of LPA5 analgesic effects via DRG and spinal cord dorsal horn, although
the LPA5 expression and function in these two regions in neuropathic pain have not been examined. In addition,
AS2717638, as the only LPA5 antagonist examined for pain modulation thus far, showed moderate in vivo
potency in both neuropathic and inflammatory pain models, where a high dose of 32 mg/kg failed to fully reverse
pain hypersensitivity, highlighting the need for optimization of this promising lead and/or identification of LPA5
antagonists based on novel scaffolds. Towards this end, we plan to examine the expression and function of
LPA5 in spinal cord and DRG to further validate the role of LPA5 in neuropathic pain using genetic and
pharmacological tools in Aim 1 and identify novel LPA5 antagnist hits via library screening and virtual screening
in Aim 2. Our goal is to identify at least two series of LPA5 antagonists for further optimization in the fugure U19
phase.

Public health relevance
Chronic neuropathic pain inflicts millions of people and opioids as the most clinically used analgesics suffer from physical dependence and abuse liability, posing serious public health challenges. Lysophosphatidic acid receptor 5 (LPA5) knockout or blockade displayed significant antinociceptive effects against neuropathic and inflammatory pain in rodents and represents a viable target for non-opioid analgesics development. Under this HEAL R61 application, we plan to further validate the role of LPA5 in spinal cord and DRG in neuropathic pain and identify additional LPA5 antagonist hits for further optimization in the U19 phase.